Novel methods to improve nuclease mediated homologous recombination

Project Summary
The 2020 Nobel Prize in Chemistry was awarded to Drs. Emmanuelle Charpentier and Jennifer Doudna for
their development of a revolutionary gene-editing tool, CRISPR/Cas9. It allows precise edits to the genome
and has swept through the life science field. It has countless applications. Scientists hope to use it to develop
therapeutic strategies for treating human genetic diseases. However, there are still several hurdles that need to
be overcome before achieving clinical applications. One of the major concerns is the undesirable insertion or
deletion (indel) events at off-target sites, as well as at the on-target site where the goal is to introduction
precise correction or mutation. Another aspect that remains to be further improved is the low efficiency of
knockin (KI) when a large size donor fragment is used, which is often below 1%. In Phase I of this STTR
project, we engineered the spCas9 protein by fusing a 36 amino acid long peptide encoded by BRCA2 Exon
27 (Brex27), which has been reported to bind RAD51 to enhance homology-directed repair (HDR). We named
this new variant the meticulous integration spCas9 (mi-spCas9), which possesses a unique combination of
desirable features, including improving knock-in rates, reducing undesirable off-target events, and reducing
undesirable on-target insertion or deletion (indel) events, providing a “one small stone for three birds” tool in
gene editing. In this Phase II project, we propose studies to further engineer Brex27, to develop an Adeno
Associated Virus (AAV) friendly mi-saCas9 and demonstrate its clinically relevant applications. Specifically, i)
in Aim 1, we will develop next-generation mi-Cas9s (mi-spCas9-v2) towards near-complete abolishment of
undesirable on-target and off-target indels; ii) in Aim 2, we will develop and optimize an AAV-friendly mi-
saCas9 for in vivo gene editing; iii) in Aim 3, we will demonstrate the advantages of mi-Cas9s in clinically
relevant applications. We expect that mi-spCas9-v2 and mi-saCas9 lead to a multi-fold increase in gene knock-
in rates and close to zero on-target and off-target indel rates. Completion of the proposed studies will enhance
the safety and efficacy of genome editing, propelling novel mi-Cas9 tools closer to an emerging multi-billion-
dollar market of basic research and therapeutic.

Public health relevance
Project Narrative CRISPR/Cas9 has become a major tool in biomedical research and offers great promise for gene editing based therapies for many human diseases. Through Phase I, we have developed miCas9 which dramatically improves the efficacy and safety in gene editing. In Phase II, we propose to develop next generation mi-Cas9s, and to demonstrate the advantages of miCas9s in clinically relevant applications.